Cancer Research Career Enhancement and Related Activities

PROJECT SUMMARY/NARRATIVE – CANCER RESEARCH CAREER ENHANCEMENT (CRCE)
One of the main goals of the Dan L Duncan Comprehensive Cancer Center (DLDCCC) at Baylor College of
Medicine (BCM) is to educate and train the next generation of cancer researchers and physician-scientists, and
to support the career development of trainees at all levels specializing in cancer research and patient care. The
CRCE Core at the DLDCCC plays a key role in integrating and developing programmatic activities to leverage
existing career enhancement activities across BCM. The CRCE Core provides coordination to ongoing career
enhancement activities, as well as initiating new directions to enrich and synergize trainees, postdoctoral fellows,
and faculty at BCM. The Core Specific Aims are: (1) To provide cancer research career enhancement activities
across the continuum of trainees; and (2) To coordinate cancer education and training activities across the
DLDCCC. These activities will be evaluated, both formatively and summatively, to gauge (1) the quality and
effectiveness with which career enhancement components are delivered and implemented, and (2) the overall
value of the experiences provided to students, fellows, and faculty members. Existing evaluation strategies
conducted by each contributing program will be leveraged to document impact on DLDCCC participants. The
goal of the CRCE Core is to provide career enhancement activities that prepares all trainees and faculty for
productive careers as biomedical cancer researchers or cancer healthcare professionals. The CRCE Core is
actively engaged with middle and high school students through BCM’s Center for Educational Outreach to
develop evidence-based models that support high quality science, technology, engineering, mathematics, and
medicine educational. For undergraduate involvement, the CRCE has taken initiatives with helping coordinate
summer research programs for students interested in cancer-focused research through the SMART program,
R25 PREP program (focused on underrepresented students), and a recently funded P20 collaborative research
and education program. The CRCE is active in graduate student enhancement through the involvement of
leadership members in the curriculum design and career development activities. Finally, the CRCE has been
enhancing the education and career development for senior-level trainees including post-doctoral fellows, both
basic science and clinical, and junior faculty through organization of cancer-related (clinical and basic science)
lecture series and facilitating career-enhancing activities in conjunction with the BCM Career Development
Center and other programs at BCM and surrounding institutions.